Randomized, double-blind, placebo-controlled trial of monthly injectable buprenorphine for methamphetamine use disorder (MURB) (CTN-0110)

Randomized, double-blind, placebo-controlled trial of monthly injectable buprenorphine for methamphetamine use disorder (MURB) (CTN-0110)